Clarifying the Role of Psychomotor Retardation in Reward-Based Reinforcement Learning Deficits in MDD: A Computational and fMRI Study

PROJECT SUMMARY/ABSTRACT
Major depressive disorder (MDD) is a highly prevalent and costly mental health disorder. A potentially important
contributor to MDD is impaired reward-based reinforcement learning (RBRL). RBRL are a set of processes
reflecting difficulty learning which actions are likely to lead to rewarding outcomes, and are clinically significant
features of MDD that predicts future depressive symptoms and worse treatment response. MDD, however, is
heterogeneous and RBRL may relate to particular MDD symptoms - specifically psychomotor retardation
(PmR), a vastly understudied but impairing aspect of MDD that may be especially detrimental for RBRL. Despite
overlapping neural circuitry between PmR and RBRL, no study has assessed the impact of PmR on RBRL-
related behavior and neural activity in MDD. This is a critical question, as the degree to which RBRL is impaired
and which RBRL processes are altered in MDD may depend on PmR. Furthermore, this is highly clinically
relevant as ameliorating RBRL deficits related to PmR in MDD may depend on targeting specific RBRL
processes. Thus, the overall goal of the proposed K23 is to clarify the role of PmR on RBRL deficits in MDD
using innovative computational modeling to parse specific RBRL processes and fMRI. Building on an ongoing
R01 (PIs: Dr. Shankman, Mittal, Walther [mentors on this K23]), Aim 1 will test whether experimentally
manipulating the demand for psychomotor speed impacts behavioral and neural indicators of RBRL in individuals
(ages 18-60) with MDD (N=66) vs. healthy controls (N=44). Aim 2 will test whether a fine-grained laboratory
assessment of PmR in MDD predicts behavioral and neural indicators of RBRL, and whether associations
between PmR and RBRL are stronger when faster psychomotor speed is required. Aim 3 will examine whether
PmR-related RBRL impairment in MDD predicts the course of depression over 1-year. The proposed career
development award also aims to provide Dr. Letkiewicz with experiences and training activities that will support
her goals of increasing her knowledge of (1) the neural and behavioral basis of psychomotor functioning in MDD,
(2) advanced computational modeling to assess reinforcement learning in the context of psychomotor symptoms,
(3) multimethod RDoC approaches to studying mechanisms of psychopathology, and (4) grantsmanship and
mentorship skills. Her training goals will primarily be accomplished through formal didactics, training with her
mentorship team, and the interdisciplinary centers and institutes at Northwestern University. Her mentorship
team consists of leading experts in MDD and transdiagnostic research (Dr. Shankman), reinforcement learning
and computational modeling (Dr. Kahnt), neuroimaging and motor systems (Dr. Mittal), and psychomotor
assessment (Dr. Walther), all of whom have all have active NIH grants and an excellent track record of mentoring
early career scientists. This award will prepare Dr. Letkiewicz to submit an R01 grant application and provide
her with the skills needed to achieve her long-term career goal of examining the unique and combined
contribution of cognitive and motor systems to psychopathology as an independent clinical scientist.

Public health relevance
PROJECT NARRATIVE The goal of the proposed project is to identify the impact of psychomotor retardation on reward-based reinforcement learning in MDD using laboratory assessments of psychomotor functioning, a psychomotor manipulation during reinforcement learning, computational modeling, and neuroimaging. This comprehensive, multimethod research project will help to clarify the critical role of psychomotor retardation on the course of MDD and identify specific mechanisms of MDD that could be targeted in future studies of depression.